ShEEP Request for Vevo 3100 Preclinical Imaging System for Rodent Models of Cardiovascular Disease & Abdominal Cancer Biology

This ShEEP request is for a Vevo 3100 rodent imaging system to support the success and growth of multi-
disciplinary research programs led by numerous VA-funded Principal Investigators at the San Francisco VA
Medical Center. The current instrument available for cardiac imaging at our medical center is of low resolution
and cannot provide 4-dimentional assessments of cardiac function, nor can it support high-resolution studies of
cardiac wall geometry, stiffness and remodeling in response to volume overload or ischemia. Features only
available on the Vevo 3100 will provide users with accurate kinetic and volumetric data for all 4 chambers of the
heart, as well as large vessels for studies of atherosclerosis and aortic aneurysm biology. The system will be
ideal to foster the success of numerous VA-funded projects that focus on developing new drugs to treat heart
failure and vascular diseases that are significant clinical problems among the Veterans. The versatility of the
Vevo 3100 will also lend itself of great value for the study of other disease models including liver and kidney
cirrhosis, as well a variety of abdominal oncology models that cannot at this time be supported with existing
instrumentation available to us.
The Vevo 3100 will add tremendously to Dr. Raffai’s VA-funded research program that studies extracellular
vesicles, including exosomes in modulating inflammation in atherosclerosis cardiovascular disease. The Vevo
3100 will provide a new dimension to test anti-inflammatory exosome-based biologics in controlling
atherosclerotic lesion burden and aneurysms in the aorta, and in preventing cardiac dysfunction and heart failure
in mice that survive myocardial infarctions. Furthermore, the ability to measure liver stiffness will allow for
collaborative studies of liver cirrhosis with Dr. Willenbring at UCSF as a minor non-VA user.
Similarly, the system will be of great value to Dr. Baker’s VA-funded program that investigates heart failure
involving the cardiac right ventricle (RV) and develop new drugs for its treatment. RV failure is a serious and
common disease that predisposes to death in patients with pulmonary hypertension including among Veterans.
The small size of the RV cannot be imaged with the current echo system but will be available via the Vevo 3100.
Drs. Simpson is a VA-funded cardiologist who works on developing new drugs for HFpEF where diastolic
dysfunction is predominant and represent 50% of all cases of heart failure. The current echocardiographic
system available to him is inadequate to support these studies and only the Vevo 3100 will solve the problem of
quantifying two key indices in HFpEF, namely diastolic function and ventricular strain.
Dr. Lau studies sex differences in human cardiovascular disease and liver cancer. He is VA-funded to study
male-specific genes and sex hormone/receptors in non-alcoholic fatty liver disease and liver cancer. He now
also studies sex differences in pulmonary arterial hypertension and cardiac remodeling, which has significant
female predominance. The Vevo 3100 will therefore be ideal for nurturing his evolving research program.
Drs. Dahiya and Tanaka, both independently VA-funded, study molecular and cellular aspects of kidney and
prostate cancer biology. Their studies focus on developing novel miRNA-based therapeutic strategies for the
inhibition of tumor progression and metastasis. The Vevo 3100 imaging system will therefore allow investigating
the biology of urological malignancies non-invasively using various mouse models available to them. Their
urology research program (five faculty members) will be immensely enriched through ready access to a Vevo
3100 imaging system to non-invasively monitor prostate, kidney and bladder cancers in rodent models.
Beyond benefitting these research programs, the Vevo 3100 will foster a rich collaborative environment to
revitalize cardiovascular and abdominal cancer research at our Medical Center, thereby providing opportunities
for cross-fertilization and for the recruitment and mentoring of clinician scientists and high-quality investigators.

Public health relevance
The goal of this proposal is to enhance basic and preclinical research at our VA medical center based on non- invasive, high-frequency ultrasound imaging for animal research. Through an array of high-resolution transducers and powerful yet simple to use software, the Vevo 3100 offers best in class 4D imaging and analysis of cardiac function and large vessel disease. It also allows imaging of fibrosis and tissue perfusion in abdominal organs including the liver and kidneys, and for monitoring tumor density in cancer models of mice and rats. The instrument is thus ideal to foster the success, growth and collaborative cross fertilization of VA patient-centric research programs led by six VA-funded investigators who focus on developing therapeutic compounds and biologics to improve cardiovascular health and cancer treatment. Beyond benefiting a set of ongoing VA-funded projects, open access to a Vevo 3100 imaging system will facilitate new project development among existing and new faculty to benefit the healthcare needs of the Veteran patient population.